Fiber design and assessment for development of a novel biomimetic medical device

Abstract. The Selective Cytopheretic Device (SCD) is an extracorporeal, blood contacting medical device
targeted to treat patients with inflammatory disease indications. SCD therapy is similar to hemodialysis in that
catheters and medical tubing are used to pass the patient’s blood through the device. The patient’s white blood
cells (WBC), also called leukocytes (LE), come in contact with the hemocompatible fibers inside the SCD.
These fibers are capable of immunomodulatory interactions with the patient’s over-active (or activated) WBC.
The SCD has been safely used in 4 human clinical studies to date, 3 trials in adults and 1 trial in adolescent
patients, with positive clinical outcomes for critically ill patients with acute kidney injury (AKI) and multiorgan
dysfunction (MOD). Long term objective: Develop a proprietary formulation of medical grade fibers with an
outer diameter (OD) ≤ 140 µm, for use in a second generation SCD (SCD2) with low blood fill volumes (BFV)
to enable the treatment of pediatric patients and critically ill adult patients with blood volume removal re-
strictions due to potential hemodynamic instability. Fibers within the current SCD (SCD1) are made of polysul-
fone (PSu) and have an OD of 280 µm. These fibers are too large to be used in SCD2, causing the BFV to be
too high, which is not safe for pediatric patients and critically ill patients. A safe BFV of <50 mL will be achieved
for SCD2 using ~140 µm OD fibers. A new, boutique fiber manufacturing facility with ISO 13485 certification
(Hollow Fiber Systems) will be utilized to manufacture medical grade fibers. Fibers will be tested in a series of
studies to rapidly develop SCD2 for clinical translation to save severely ill patients' lives.
In the previously completed Phase I project period, the way the SCD1 used in clinical trials works was
characterized, called the mechanism of action (MoA). Main features of MoA that were elucidated include: LE
adhesion to SCD fibers, with a specific adhesion of monocytes (MO) and neutrophils (NE). To advance propri-
etary fiber development, an optimal range of hydrophilic agent to add to the PSu material during fiber produc-
tion was established. In this Phase II proposal, proposed studies include: Aim 1. Characterize proprietary med-
ical grade fibers produced by custom manufacture. Evaluate fibers in miniaturized prototype SCD2 utilizing in
vitro blood circuit (IVBC) with human blood. Aim 2. Produce full-size pediatric-SCD2. Evaluate SCD2 design in
IVBC studies with porcine blood to assess SCD-LE interactions and hemocompatibility. Aim 3. Evaluate SCD2
in a clinically relevant porcine model of severe sepsis (SS) associated-AKI. Aim 4. FDA regulatory biocompati-
bility, sterilization and shelf-life testing of SCD2. Health Related Impact: Preclinical data generated from this
proposal will be included in regulatory submissions to apply for IDE approval from the FDA to initiate clinical
trials for the evaluation of SCD2 therapy in both acute and chronic disease indications, staring with orphan dis-
eases: pediatric AKI, atypical hemolytic uremic syndrome (aHUS) and cardiorenal syndrome (CRS) patients
with left ventricular assist device (LVAD) destination therapy (DT) that may benefit from SCD2 therapy.

Public health relevance
Narrative The Selective Cytopheretic Device (SCD) is a medical device applied during dialysis or hemofiltration that is designed for blood to flow through it, with fibers inside the device that can interact with severely ill patient's white blood cells in order to reset and normalize their immune system. The current SCD is designed for adults with kidney disease and organ failure but cannot be used on children or other severely ill patients that can't withstand and aren't safe if large amounts of blood is taken out of their bodies to be used in a blood circuit. This proposal seeks to test proprietary, custom-made fibers in a new, smaller 2nd generation SCD (SCD2) in large animal studies and FDA safety tests, to prepare for future use to treat sick patients.